Core A: Biostatistics and Data Management

PROJECT SUMMARY / ABSTRACT – CORE A
Core A supports the program project in two major areas: (1) Biostatisticians in this core provide statistical support
to all of the research projects. This support includes all phases of study design for both pre-clinical studies and
clinical trials, including study conduct, data analysis, and reporting and interpretation of results. (2) The core
supports data management for the clinical trials proposed. The core supports the nonmyeloablative transplant
database and connectivity between that database and other data resources. It also supports all aspects of data
gathering and data coordination for the proposed clinical trials, as well as long-term follow-up for patients on
studies from the current funding period.

Public health relevance
PROJECT NARRATIVE - CORE A The core supports the research projects by providing database support, as well as statistical support for designing and analyzing the research studies.